Radiochemistry Food Defense

Missouri Department of Health and Senior Services State Public Health Laboratory Project Abstract for FOA PAR-20-105 Laboratory Flexible Funding Model Discipline C (Radiochemistry): Track 1 Food Defense Purpose: The Missouri Department of Health and Senior Services (DHSS) State Public Health Laboratory (MSPHL) seeks FDA cooperative agreement funding opportunity to prove presence or absence of radioactive contamination and identify the identities of radionuclides present in human or animal food samples through screening. The data generated will be used to characterize the extent of food contamination, for following trends, and for calculating intakes. The goals and outcomes of this project include the following: 1. The MSPHL will supply triage data from sample testing performed to determine whether further analysis is needed. 2. The MSPHL will utilize semi-quantitative results from sample testing performed to determine if contamination is well above or well below regulatory limits. 3. The MSPHL will participate in FDA-requested triage exercises, and/or surveillance activities to support and maintain readiness. 4. The MSPHL will participate in national security event exercises, as available. Page 1 of 1